ORAL ZOLOLRESTAT IN NORMOTENSIVE, TYPE I DIABETICS WITH INCIPIENT NEPHROPATHY

Substantial clinical and experimental evidence now exists to suggest that increased flux of glucose throught the ployol pathway may play and important role in th pathogenesis of the long-term complications of diabetes, particularly neuropathy, nephropathy, microvascular disease, and cataractogenesis.